Regulation of alternative cleavage and polyadenylation

PROJECT SUMMARY
Most mammalian genes harbor multiple cleavage and polyadenylation sites, or PASs, resulting in mRNA
isoforms with different coding sequences (CDS) and/or 3’ untranslated regions (3’UTRs). Alternative
cleavage and polyadenylation (APA) is rapidly recognized as an important layer of gene regulation, affecting
gene expression, protein diversity and mRNA metabolism. The APA pattern of genes varies across
cell/tissue types, is dynamically regulated in proliferation, differentiation and development, and alters in
response to extracellular cues. The mechanisms of APA, however, are poorly understood. Our long-term
goal is to understand the ‘regulatory code’ of APA in different cells/tissues under physiological and
pathological conditions. In this proposal, we have three specific aims: First, we will systematically examine a
set of termination factors in APA regulation. Second, we will examine the interplay between 3’ end
processing and splicing in APA regulation. Third, we will develop a genomic method to alter APA. We
expect that the result of this grant will provide comprehensive understanding of the mechanisms of APA and
tools to regulate gene expression through APA.

Public health relevance
PROJECT NARRATIVE Most mammalian genes express alternative cleavage and polyadenylation (APA) isoforms with different coding sequences (CDS) and/or 3’ untranslated regions (3’UTRs). We plan to unravel how APA is regulated and how regulation of APA can be used to change gene expression.